Predevelopment of VV8220, a Gut-selective CRAC Channel Therapeutic for Ulcerative Colitis

Vivreon Biosciences, LLC
4940 Carroll Canyon Rd., Ste. 110
San Diego, CA 92121
[email]
NIAID PA-23-230
Project Summary
Ulcerative colitis (UC) is the most common form of inflammatory bowel disease affecting up to one in 5,000
individuals. The pathologic inflammation occurs in the inner lining of the colon and rectum due to an inappropriate
response of resident leukocytes to normally tolerated bacteria and other pro-inflammatory material in the gut.
This results in potentially life-threatening ulcerative lesions and significant disruption to quality of life. Currently
indicated small molecule and biologic drugs are not effective in all patients, or many patients become
unresponsive to therapies over time, and additional treatment options are needed. One promising and novel
therapeutic approach to controlling UC is to restrict anti-inflammatory drug action to the inner lining of the gut
where the local inflammatory response is most extreme, thereby simultaneously limiting systemic anti-
inflammatory side effects of the drug. An orally available drug with such gut-restricted properties would be acting
similarly to topical agents applied to the skin to control autoimmune inflammation of the skin. The leukocyte Ca2+
release activated Ca2+ (CRAC) channel is operative on gut monocytes and T cells (primary cellular drivers of
UC), is triggered by leukocyte receptors for foreign antigens, and the CRAC pathway regulates many pro-
inflammatory genes in these cells through activation of NFAT and NF-B transcriptional activity. These attributes
make the CRAC channel a suitable target for development of a gut-restricted small molecule drug.
Vivreon’s candidate therapeutic CRAC channel blocker exhibits physical properties consistent with a gut
restricted oral drug candidate, including strong potency and limited systemic exposure upon oral dosing. Vivreon
seeks NIAID Phase 2 funding for investigational new drug (IND)-enabling good laboratory practice (GLP) toxicity,
safety, and genotoxicity studies. Specifically, NCI funding will go towards two-species GLP 28-day toxicity
studies, GLP safety pharmacology and genetic toxicology, GLP pharmacological respiratory safety assessment,
and GLP cardiovascular telemetry. Activities in this proposal will run in parallel with chemistry manufacturing and
controls (CMC) processes. Completion of these studies will support and be written up in an IND application, with
the final milestone being IND submission to the US Food and Drug Administration (FDA).

Public health relevance
Vivreon Biosciences, LLC 4940 Carroll Canyon Rd., Ste. 110 San Diego, CA 92121 [email] NIAID PA-23-230 Project Narrative Ulcerative colitis (UC) is the most common form of inflammatory bowel disease and imposes large quality of life and financial cost burdens on the patient. Additional effective therapeutics that operate via novel mechanisms are needed to control the disease and provide relief. Vivreon’s small molecule therapeutic candidate compound, which blocks a novel target appropriate for the fight against UC, will be advanced into a full clinical development program as an oral therapy option for these patients.